Conversational Agent to Improve Guideline Concordant Care for People with Cervical Cancer Screening Abnormalities

PROJECT SUMMARY / ABSTRACT
Cervical cancer is almost entirely preventable with appropriate screening and management of abnormal results,
yet in the US, over 14,000 individuals were diagnosed with cervical cancer in 2023, and over 4,000 died. Black,
Hispanic, and low-income individuals have higher cervical cancer incidence and mortality. Over 20% of those
diagnosed with cervical cancer did not receive appropriate diagnosis and treatment after an abnormal result.
The FDA approved HPV self-collection, a new form of screening, in May 2024. Self-collection will expand access
to screening, but increases by nearly twofold the number of patients requiring immediate follow-up after an
abnormal result. Fear of cancer, poor communication, and difficulty scheduling follow-up appointments were key
barriers. Embodied Conversational Agents (ECAs) are animated computer characters that simulate face-to-face
conversation between a patient and a caregiver, using both verbal and nonverbal conversational behavior, to
provide a natural and intuitive computer interface that is accessible to patients of all levels of health and computer
literacy. We have successfully developed and evaluated this interface in several clinical trials to motivate health
behavior change for a wide range of populations, including a pilot evaluation of an ECA that promotes HPV
vaccination for the families of patients with cervical pre-cancer and cancer. In this project we will adapt this
technology to produce English and Spanish smartphone ECAs for follow-up of abnormal cervical cancer
screening results (ECA-CCSA). The ECA will provide follow-up recommendations and motivational interviewing
to patients with abnormal screening test results and will facilitate communication with clinic staff. Follow-up
promotion over time can lead to completion of needed testing among those with barriers, and the ECA can
conduct repeated conversations with patients both prior to and following clinic visits. We will evaluate ECA-CCSA
in a randomized controlled trial for patients aged 21 and older with abnormal screening test results to evaluate
ECA-CCSA, comparing usual care (UC) versus usual care plus the ECA (UC + ECA-CCSA). The research team
is nationally recognized as leaders in cervical cancer prevention, health literacy, and innovative technologies to
improve health. This study will advance our research on the development of easy-to-use technologies to
empower patients. This scalable approach has significant potential to increase follow-up after an abnormal
screening test result, which is timely as clinical settings are currently adopting HPV self-collection technologies.
If successful, our team will promote the ECA-CCSA through national networks for broad implementation and
work to adapt ECA-CCSA to other languages and settings.

Public health relevance
PROJECT NARRATIVE Many people who receive abnormal results from cervical cancer screening do not follow up with appointments that would allow treatment of precancer and would prevent cancer. In this project, we will develop an animated health coach that works on a smartphone to guide them through the cervical cancer screening and care process to ensure they receive the follow up and treatment they need to prevent cancer. This project is timely because HPV self-collection was recently approved as a new form of screening that increases the number of people requiring immediate follow up.